Training Program for Applied Research and Development in Genomic Medicine

ABSTRACT
Healthcare professionals, genomic scientists, and numerous other stakeholders are embracing the advances in
healthcare that are possible, and with increasing frequency are being delivered, through approaches that
employ genomics to improve care and patient outcomes. To ensure that we can continue to expand upon and
deliver the full potential of such an approach requires a highly qualified cadre of clinician-scientists, scientists,
and clinicians working collaboratively to advance discoveries and implementation in genomic medicine. This
proposal for continuation of our post-doctoral genomic medicine training program, “Program for Applied
Research and Development in Genomic Medicine or PARADIGM,” leverages our successes and lessons
learned from the first cycle of funding to: 1) refine an integrated training program in genomic medicine, which
includes didactic, research, clinical, and professional development activities; 2) recruit promising junior
investigators and train them using an interprofessional and interdisciplinary mentoring approach; and 3)
evaluate the PARADIGM training program for achievement of learning objectives, success, and long-term
productivity and career progress of trainees. This training program for MDs, PharmDs, PhDs, and other clinical
specialists at the doctoral level is based on four premises: 1) Genomic medicine must be advanced by a cadre
of clinicians and PhD scientists from a variety of specialty areas; 2) a team approach is essential; 3) genomic
medicine will require a diverse workforce of leaders; 4) the University of Florida is an ideal environment for this
training. To train individuals to meet these needs, PARADIGM will provide a multi-year, integrated,
multidisciplinary program comprised of four major components: 1) a Didactic component of required and
optional coursework; 2) a Mentored Research component involving a defined research project under the
mentorship of an accomplished genomic medicine scientist and clinician; 3) a Clinical Genomic Medicine
component that integrates trainees into the genomic medicine clinical practice setting; and 4) a Professional
Development component including training in research integrity; administrative, fiscal and regulatory training;
and grant-writing skills. Training across these four components will be tailored to the experience and needs of
each trainee, but will be concentrated in three cores of expertise at UF: pharmacogenomics, cancer genomics,
and disease susceptibility genetics/genomics. The program will be led by two highly accomplished leaders in
the field together with a cadre of highly talented, collaborative, multidisciplinary mentors. PARADIGM will
undergo continuous evaluation and quality improvement to ensure long-term success of the trainees. Upon
program completion, each trainee will be expected to possess knowledge and skills that will enable them to
manage the challenges of evidence generation and clinical use of genomic medicine.

Public health relevance
PROGRAM NARRATIVE The overall goal of this post-doctoral training program in genomic medicine is to provide clinical/translational scientists with a multiyear training program comprised of didactic, research, clinical genomic medicine, and leadership training. At the end of their training period, trainees possess knowledge and skills that will enable them to manage the challenges of evidence generation and clinical use of genomic medicine.